PFAS induced alterations in reward processing

Per- and polyfluoroalkyl substances (PFAS) are widespread environmental contaminants that have been
investigated as developmental toxicants, with little information on long-term neurotoxicity and clinical
outcomes. Our preliminary data suggest that PFAS may produce neurotransmission changes relevant to
psychiatric disorders involving abnormal reward processing, specifically anhedonia. We will test the hypothesis
that: early life PFAS exposure will produce alterations in reward processing mediated through specific
neurotransmission targets. Importantly, the hypothesis will be tested in animal models and humans, utilizing
innovative translational approaches. We will test our hypothesis through 3 aims. Aim 1 will establish a brain -
specific translational PFAS dosing regimen in mice, based upon published and preliminary data from human
brain samples and sentinel animal studies. Here, we will develop a translational dosing strategy, specific to brain
levels that is expected to considerably increase the human health relevance of these and future studies. This aim
sets the stage for studies on the potential role of PFAS exposures in psychiatric disorders. Aim 2 will determine
if PFAS exposure produces alterations in behavioral phenotypes relevant to reward processing in mice. In light
of our preliminary data and the gap in the literature, there is a critical need to evaluate developmental
neurotoxicity in higher order species. We will assess the emergence of neurological phenotypes through
neurobehavioral analyses, neurotransmitter measurements, neuropathology studies, and determination of the
biochemical underpinnings of a reward processing phenotype. Aim 3 will determine whether serum PFAS
(individual compounds or as a mixture) are linked to human reward processing deficits. To achieve bi-
directional translation, we will conduct human studies informed by our animal data. Conversely, data from this
aim will inform ongoing animal studies. To identify links to psychiatric disorders, we will conduct a cross-
sectional study of adults aged 18 to 30 years. In this study we will: identify correlations between serum PFAS,
self-reported anhedonia severity, and clinician-rated anhedonia severity; test for clinical specificity by
examining correlations with broader symptoms of depression, mania, and psychosis; and identify correlations
between serum PFAS and neurophysiological measures of reward sensitivity, which may represent intermediate
phenotypes with disease relevance. Our findings may suggest that individuals with high PFAS levels be
carefully monitored for the emergence of psychiatric symptoms. We expect this project to have a significant
impact on the understating of environment influences of neuropsychiatric diseases. For the first time, we will
establish whether specific PFAS exposures may influence the etiology of reward processing disorders. We will
do so in both animal models and human studies – where resultant data from each line of research informs each
other to achieve bidirectional translation with respect to experimental design and interpretation.

Public health relevance
Environmental exposures may be important in the etiopathogenesis of psychiatric diseases involving reward processing deficits. This proposal examines the role that per- and polyfluoroalkyl substances (PFAS) may have in psychiatric risk, especially for an anhedonia phenotype with relevance to depression. Given widespread exposure to PFAS (detectable in most human blood), it is critical to examine whether and how exposures may influence the risk of neurological disease and to determine whether those with high PFAS levels should be monitored for heightened reward processing deficits.